Promoting Health, Safety, and Recovery Training for COVID-19 Essential Workers and their Communities

Summary/Abstract: Promoting New England Recovery Centers for COVID-19
Essential Workers and Their Communities
The New England Consortium-Civil Service Employees Association (TNEC-CSEA) is a worker
health and safety training partnership directed by the University of Massachusetts Lowell
(UML) based in its Department of Public Health, College of Health Sciences and the UML
Climate Change Initiative. Since 1987, TNEC-CSEA has delivered participatory hands-on
training to workers in hazardous waste operations and emergency response. Consortium
partners include four Coalitions for Occupational Safety and Health (COSH organizations:
ConnectiCOSH, MassCOSH, NHCOSH, and RICOSH) and the Civil Service Employees
Association (CSEA), Local 1000, American Federation of State, County, and Municipal
Employees (AFSCME). TNEC-CSEA’s previous experience in infectious disease training began
2008 and in 2021, TNEC-CSEA established two Recovery Centers: one in Connecticut as a
partnership between ConnectiCOSH and the Naugatuck Valley Project (based in Waterbury,
CT); and another in Massachusetts, led by MassCOSH in partnership with community
organizations in East Boston, Dorchester, Brockton, and New Bedford. TNEC-CSEA proposes
six Recovery Center projects: 1) a partnership with the Lowell Community Health Center in
Lowell, MA, to train community health workers and community residents on Infectious Disease
Preparedness, Disaster Preparedness, and CPR/First Aid; 2) a partnership with the Coalition for
a Better Acre in Lowell, MA, to support their COVID-19 community education and support
programs; 3) an expansion of the recovery center partnership between ConnectiCOSH and the
Naugatuck Valley Project to include training and support for domestic workers around the
infectious disease and chemical hazards they face on the job; 4) an expansion of the MassCOSH
recovery center with a new partnership with the Massachusetts Association of Community
Health Workers to provide training and support on mental health and resilience to frontline
community health workers; 5) a TNEC New England program to train bilingual trainers in the
OSHA Outreach Trainer program (OSHA 500 and OSHA 510), in partnership with the OSHA
Training Institute Training Institute in Manchester, NH; and 6) development of twelve (12) 2-
hour online, self-directed health and safety training modules that support and enhance the
recovery center trainings and educational programs.